Administrative Core

This Specialized Program of Research Excellence (SPORE) grant is intended to support multi-project, interdisciplinary
and multi-institutional translational research in glioma. The governance structure of this Dana- Farber/Harvard Cancer
Center (DF/HCC) SPORE grant provides the foundation for the implementation, execution, and ultimate success of all
projects and cores. The Administration Core serves as the “hub” for this governance structure and aims to achieve a
number of specific objectives as defined below. We will execute a plan that provides experienced, centralized program
leadership and administration. The Glioma SPORE Director and Co-Directors are senior administrators, institutional
leaders, and researchers who have worked together on the current funding period for this SPORE and on prior DF/HCC
initiatives and, consequently, provide consistent, strong, complementary leadership for the grant. The trans-institutional
administrative team consists of senior personnel at DF/HCC institutions who have worked together effectively in the
current and prior funding periods of this grant. We include a senior clinical investigator in the Administration Core to
supervise Glioma SPORE- specific clinical trials, and to enable this Glioma SPORE to capitalize on existing DF/HCC P30
Cores to support these types of studies. We have established and utilized an effective internal and external committee
structure to provide multidisciplinary expertise, advice, and oversight of the program. Each of the committees consists of
collaborative, complementary members who have worked together in the current and prior funding periods of this SPORE
or on prior projects. A series of regular Glioma SPORE meetings involving both administrative and scientific SPORE
personnel will continue to facilitate close collaboration, troubleshooting, and monitoring of the SPORE program. We will
continue an effective internal and external communications program, which includes a Glioma SPORE-specific
component. An established and extensive DF/HCC communications infrastructure is utilized to promote open, regular,
trans-institutional communication regarding SPORE opportunities and activities.

Public health relevance
Project Narrative Primary brain tumors are the third leading cause of cancer-related death among all persons 15-39 years of age. In the fullness of time, the work that we propose with targeted therapies could change the standard of care and improve adult and pediatric patients with gliomas. The Administration Core serves as the "hub" for the governance of this SPORE research program.